ANDROGEN, STIMULATION OF GH SECRETION

We hypothesize that testosterone's growth hormone (GH) stimulatory effect is mediated by its aromatization to estradiol. To test this hypothesis, we will compare the effects of testosterone and the non-aromatizable androgen, oxandrolone, on spontaneous GH secretion patterns in children with hypogonadism or abnormal delay in pubertal development.